Administration Core

Project Summary /Abstract - Administrative Core This core provides the administrative leadership, management and oversight of the ALS-ENABLE Resource. The Resource Director will provide budget oversight for the whole project, set the scientific goals for the whole program in collaboration with the deputy directors and Component leads, ensure milestones are met in a timely manner, assess the progress in the individual Components, make significant changes in resource composition if necessary, and report progress to NIH staff. The Administrative Core will oversee the development of a web- portal, which will serve as a single point of contact for users of all the crystallography beamlines and the bioSAXS beamline at the ALS.